MODULATION OF BETA BLOCKADE DURING PROPAFENONE THERAPY--LOW DOSE QUINIDINE

Quinidine co-administered will increase the degree of beta blockade and decreased variability in the extent of beta blockade during propafenone therapy will be tested.